Identifying Temporal Sequences of Exposures in Type 1 Diabetes Etiology

PROJECT SUMMARY/ABSTRACT
Type 1 diabetes mellitus (T1DM) is a chronic autoimmune disease in which an inability to produce
insulin results in glucose dysregulation. Patients with T1DM experience significant disease burden, making
disease prevention a priority. Environmental exposures are implicated in immune activation and progressive
destruction of insulin-producing β-cells that lead to overt T1DM. Despite several studies investigating the role
of environmental exposures in T1DM etiology, no causative exposures have been identified. One reason is
limited understanding of the timing and combination, i.e., temporal sequences, of exposures that contribute to
T1DM etiology. Modifying these exposures may offer safe and cost-effective approaches to prevent or delay
T1DM disease onset. Therefore, a clearer understanding of the temporal sequences of exposures that drive
T1DM etiology is needed to inform prevention strategies and reduce disease burden.
Current prevention strategies focus on altering early disease timepoints in the natural history of T1DM,
including immune activation and progressive β-cell destruction. Immune activation is monitored using islet
autoantibodies, and β-cell destruction is approximated using presymptomatic T1DM staging. The temporal
sequences of exposures underlying these early disease timepoints are poorly understood. Therefore, this
proposal seeks to identify temporal sequences of exposures that increase risk for T1DM by modulating islet
autoantibody trajectories and progression through presymptomatic staging. The specific aims of this proposal
are to 1.) determine if temporal sequences of exposures that jointly alter islet autoantibody trajectories increase
risk for T1DM, and 2.) determine if temporal sequences of exposures that are associated with stages of T1DM
can predict presymptomatic progression of T1DM. This work will be investigated using state-of-the-art temporal
machine learning and data mining methods with data from the Environmental Determinants of Diabetes in the
Young (TEDDY) study. Successful completion of this project will improve the clinical translatability of exposure
modification in T1DM prevention by providing further insight into the timings and combinations of exposures
that are implicated in early T1DM disease timepoints. The analytical pipelines developed in this proposal will
also serve as a framework for elucidating complex temporal interactions in other exposure-driven diseases.
This application outlines a rigorous scientific and clinical training plan at the University of Utah.
Computational training in temporal machine learning, joint trajectory modeling, and sequential pattern mining in
the Department of Biomedical Informatics will be combined with longitudinal clinical experiences in the Division
of Pediatrics and Endocrinology. These activities, augmented with mentorship from scientific and clinical
experts, will enable the applicant to become a successful physician-scientist in pediatric endocrinology.

Public health relevance
PROJECT NARRATIVE Type 1 diabetes mellitus (T1DM) is associated with significant patient burden, and environmental factors are thought to trigger disease onset. Modifying these exposures may offer safe and cost-effective approaches to prevent or delay T1DM; however, the timing and combination of exposures that contribute to T1DM etiology are poorly understood. This study aims to identify temporal sequences of exposures that contribute to T1DM with the long-term goal of improving the clinical translatability of exposure modification in T1DM prevention.